TESTING OF A POSSIBLE ALZHEIMER VACCINE (DNA Aβ42 IMMUNIZATION) VIA NEEDLE LESS JET INJECTION IN TWO ANIMAL MODELS

Project summary/Abstract Alzheimer’s disease (AD) is the most common form of dementia found in the elderly and disease progression has been strongly associated with accumulation of Amyloid beta 1-42 (Aβ42) in brain. An immune-mediated approach as a preventive intervention to reduce amyloid plaques without causing brain inflammation is highly desirable for future clinical use. Genetic immunization, in which the immunizing agent is DNA encoding Aβ42, has great potential because the immune response to DNA is generally non-inflammatory, and differs quantitatively and qualitatively from the immune response elicited by peptides, which is mainly inflammatory. DNA immunization has historically been proven difficult to apply to larger mammals. A potential barrier to use DNA immunization in large mammals is the method for delivery of the DNA antigen. Over the last decade, substantial progress has been made to increase the effectiveness of DNA delivery and immune responses, respectively. Electroporation had been shown to greatly enhance DNA immunogenicity in clinical trials, and DNA electroporation has been reported as highly tolerable by the patients with few side effects. This proposal is aimed at translating our established gene gun DNA Aβ42 delivery immunization approach in mice into the clinically more feasible method of needle-free intradermal DNA delivery via jet injection possibly in combination with electroporation to trigger DNA uptake and immune responses. We will use wild-type mice and New Zealand White rabbits as a large mammal model to test our DNA Aβ42 delivery methods, and to demonstrate antibody production and safe immune responses. We will use the 3xTg-AD mouse model to demonstrate that DNA Aβ42 immunization using jet injection and/or electroporation is effective to break tolerance against self-antigens, leading to the production of sufficient anti-Aβ42 antibody levels to clear Aβ42 and prevent amyloid accumulation in the brain without causing inflammatory side effects. This study is designed to optimize the DNA delivery for possible testing in human trials.

Public health relevance
Project Narrative The possibility of an immune mediated approach as a preventive or therapeutic intervention that reduces amyloid deposition in brain without causing brain inflammation has great impact for future clinical use. This grant is aimed at transferring our DNA Aβ42 immunization approach from the delivery method of the gene gun into the clinically more feasible method of intradermal DNA injection delivery with a jet injector already used in clinical trials. We hypothesize that with the outlined experiments, we will be able to recapitulate all the findings we made previously using DNA Aβ42 gene gun delivery, and continue into the direction of a possible clinical use of DNA Aβ42 immunotherapy for AD patients.